10TH INTERNATIONAL CONFERENCE ON MOAB IMMUNOCONJUGATES

The Tenth conference will provide an overview of the progress in the field monoclonal antibody conjugates for clinical use in cancer, and commemorate the twentieth anniversary of the discovery of monoclonal antibodies. This conference continues to bring together world recognized investigators from academia, industry and government to provide a forum for the presentation and discussion of the latest results of clinical trials in man, as well as pre-clinical studies. The program will continue the successful format of 5 half-day sessions over a 2 1/2 day period. The sessions will include both invited speakers and the presentation of proffered abstracts describing recent clinical and pre-clinical data. The scope of the tenth conference will has been broadened to include presentations on the use of ligands as an alternative to antibodies for tumor targeting. In addition, several workshops focusing on certain issues, such as radiopharmaceuticals, radiodosimetry and combined approaches using antibodies with other agents are included. Finally, there will be an anniversary commemorative session on antibody engineering featuring papers on humanized antibodies made by recombinant techniques, human antibodies produced by in vitro immunization, transgenic mice, and combinatorial library expression systems. Dr. Cesar Milstein, one of the discoverers of monoclonal antibodies and a Nobel laureate, is being invited to delivery the key not address in this session. This conference is of major interest for investigators in this area of research such as tumor immunologists, biotechnologists, medical oncologists, radiation therapists, nuclear medicine immunologists, nuclear medicine physicians and other interested health professionals and researchers working in this field, and brings together investigators and clinicians from academia, industry and government.